Diet-mediated regulation of fatty acid saturation impacts cancer progression and therapy responses.

Project Summary/Abstract
Many “anti-cancer” diets are promoted in popular culture for cancer prevention and treatment, reflecting the
enthusiasm of patients, clinicians, and researchers alike for using diet to improve patient prognosis. Many of
these dietary recommendations, however, are poorly supported by scientific evidence. While diet is a known
contributor to cancer risk, how diet influences survival in patients who already have cancer is poorly understood.
This is a key distinction because many patients are only motivated to make dietary changes after receiving a
cancer diagnosis. Moreover, because dietary advice for patients must be given in the context of other treatment
strategies, it is important to determine how diet might enhance or antagonize standard-of-care and emerging
cancer therapies. Therefore, there is a critical need to define the molecular mechanisms that underlie dietary
effects on cancer progression and therapy before it will be possible to integrate diet effectively into cancer
treatment. Uncovering these mechanisms will transform precision nutrition therapeutic approaches, which aim
to tailor dietary changes with particular therapies to target specific tumor types.
Recent work in cancer metabolism has shown that changes to nutrient levels in the tumor microenvironment
are key to determining the impacts of dietary interventions on tumor metabolism, growth, and responses to
therapy. Interactions between whole-body and tumor lipid metabolism have a central role in linking diet with
cancer progression. Lipids are synthesized from fatty acids, which can be saturated, monounsaturated, or
polyunsaturated, depending on the number of double bonds they contain. Cellular fatty acid saturation is tightly
regulated to maintain membrane structure and cellular function. Previous data shows that dietary manipulations
can alter the balance between saturated and unsaturated fatty acids within tumors. The proposed research will
define the mechanisms by which diet dysregulates tumor fatty acid saturation states to influence tumor
progression and therapy responses. Mouse pancreatic and lung cancer models will be used to examine: (1) how
a caloric restriction diet alters tumor-intrinsic polyunsaturated fatty acid metabolism, thereby defining dietary
contexts under which this pathway can be therapeutically targeted; (2) how excessive saturated fatty acid
consumption induces lipotoxic stress in tumors and generates resistance to cancer therapy, the reversal of which
could be a strategy to enhance therapy responses; and (3) how manipulating the fat type in diets alters tumor
metabolism and growth in a predictable manner by providing tumors with different relative amounts of saturated,
monounsaturated, and polyunsaturated fatty acids, leading to dietary fat type-associated metabolic
dependencies that can be therapeutically exploited. These studies will define the metabolic mechanisms
underlying how diet-induced changes to whole-body and tumor lipid metabolism interact with cancer therapies.
The expected outcomes will set the foundation for the improved design of future translational studies that use
dietary interventions as an assistive therapy for cancer treatment.

Public health relevance
Project Narrative To effectively integrate diet into cancer treatment, there is a critical need to define the molecular mechanisms that control the effects of diet on cancer progression and therapeutic efficacy. Changing the types of lipids that are available in the tumor microenvironment directly impacts cancer cell lipid metabolism, which becomes a major driver of dietary effects on tumor biology. To demonstrate the critical role of lipid metabolism in linking diet to cancer, the proposed research will examine how different dietary interventions impact cancer progression and therapy by altering the balance between saturated versus unsaturated fatty acids within tumors.